The impact of aberrant m5C mRNA modification on translation initiation and cancer

PROJECT SUMMARY
Post-transcriptional modifications on mRNAs are critical for modulating protein synthesis and
maintaining cellular homeostasis. mRNAs are decorated with numerous chemical modifications, including 5-
methylcytosine (m5C), which is enriched in regulatory 5¢ untranslated regions (5¢-UTRs). Aberrant m5C
methylation caused by overexpressed methyltransferases in cancer cells is known to stabilize specific
oncogenic mRNAs, thereby promoting cell proliferation and tumorigenesis. However, how aberrant m5C
methylation of 5¢-UTRs affects translation initiation and dysregulates protein synthesis remains largely
unknown. Dysregulated translation of oncogenes and tumor suppressors is likely to contribute to the
pathogenic effects of dysregulated methyltransferase expression in tumors. The primary objective of this
proposal is to determine the regulatory role of dose-sensitive m5C modification in the early stages of translation
and uncover its direct impact on ribosome recruitment to mRNA 5¢-UTRs. To study physiological m5C residues,
I first purified the key mRNA modifying members of the NOL1/NOP2/SUN (NSUN) family of
methyltransferases, NSUN2 and NSUN6, and verified their methyltransferase activities using known targets.
Here, I will screen ~35,000 human endogenous 5¢-UTR sequences from multiple tissues, encompassing all
genetic isoforms, for m5C installation by NSUN2 and NSUN6. My preliminary computational analysis indicates
the presence of thousands of potential m5C targets in this 5¢-UTR pool. The overarching hypothesis of this
proposal is that m5C is dose-dependently installed on 5¢-UTRs and quantitively impacts translation initiation. To
test this hypothesis, I will employ an innovative high-throughput approach developed in our lab, direct analysis
of ribosome targeting (DART), to quantify ribosome recruitment on UTR pools methylated with varying
concentrations of NSUN2 or NSUN6. Aim 1 will identify dose-sensitive m5C targets through bisulfite
sequencing, measure m5C-dependent changes in ribosome recruitment, and validate methylation-sensitive
translation activity in cancer cells. Aim 2 will identify and characterize trans-acting RNA binding proteins that
modulate m5C-mediated translational control. Together, the proposed work will elucidate how aberrant m5C
methylation, caused by overexpression of NSUN2 and NSUN6, mediates dysregulation of translation in cancer
cells. My results are expected to reveal novel and fundamental mechanisms of translation initiation in human
cells and may uncover new therapeutic targets for cancers with overexpressed NSUN2 and NSUN6.

Public health relevance
PROJECT NARRATIVE: Aberrant mRNA modifications result from overexpressed methyltransferases in cancers, leading to dysregulation of protein synthesis and more aggressive tumors with worse patient outcomes. The project aims to identify aberrant m5C modifications on 5' untranslated regions of mRNAs and determine how they impact translation initiation and protein expression. The findings could generate new leads for development of novel targeted therapeutic strategies for cancers with aberrant m5C methylation due to elevated expression levels of mRNA methyltransferases.